Lacritin Regulation of Homeostasis and Ocular Surface Health

Dry eye is a chronic disruption of ocular surface homeostasis. Evidence is accumulating for tear protein 'lacritin'
and its natural C-terminal proteoforms 'N-94' and 'N-94/C-6' as master regulators of ocular surface homeostasis.
Accordingly, their selective deficiency or absence in dry eye may be viewed as a major risk factor or even cause
of dry eye for which replacement therapy may be a logical treatment approach. Indeed, in NCT03226444, a
recent large multi-center, randomized, placebo-controlled, double masked phase 2 clinical trial, topical N-94/C-
6 significantly restored homeostasis within two weeks in Primary Sjögren's Syndrome dry eye - the most severe
dry eye group. Although we understand in general how lacritin works, many details are missing - most notably
the identity of the signaling receptor, and gaps in proximal and distal signaling. We recently performed unbiased,
genome-wide CRISPR/Cas9 death screens. Our death screens identified genes that when disrupted by
sgRNA/Cas9 editing abrogated the capacity of N-94 to restore homeostasis of cultured human corneal (HCE-T)
cells stressed with lethal doses of IFNγ and TNF in an in vitro model of dry eye. Out of 19,114 genes targeted
by 76,441 sgRNA's, with 1,000 controls, GPR87 was the top receptor hit as validated by targeted CRISPR/Cas
9 editing, shRNA knockdown without or with GPR87 cDNA complementation, and syndecan-1 pulldown. GPR87
is expressed in the cornea, shares lacritin signaling mediators (pertussis toxin sensitive G-protein, IP3, calcium,
NFAT), and although considered by some to be deorphanized as a lysophosphatidic acid (LPA) receptor, a
recent well-controlled study by others failed to detect specific LPA binding in competition nor functional
experiments. Nor does LPA rescue HCE-T cells. Our working hypothesis is that GPR87 with syndecan-1 are
essential elements of the lacrimal - ocular surface axis. Our immediate goal is to elucidate how GPR87 interacts
with syndecan-1 and both N-94 and N-94/C-6, and explore CRISPR/Cas9 mediator hits to expand our
understanding of lacritin signaling mechanisms. Our long-term goal is to harness this information towards the
effective and lasting treatment of dry eye disease.
University of Virginia Charlottesville Virginia
University of California San Francisco San Francisco California

Public health relevance
Finding an effective treatment for dry eye is challenging. Topical N-94/C-6 ('Lacripep'), a natural fragment of the tear protein lacritin (deficient in dry eye) addressed sign and symptom within two weeks in the recent phase II trial NCT03226444. Here we work out more fully the mechanisms of action by characterizing the receptor complex, including proximal and distal mediators, and develop a model.